Multifunctional phase sensors for probing and manipulation of intracellular biomolecular condensates

Project Summary/Abstract
Intrinsically-disordered proteins (IDPs) are drivers of intracellular self-assembly. Powered by highly multivalent
interactions, IDPs organize subcellular assemblies (biomolecular condensates) governed by liquid-liquid phase
separation (LLPS) dynamics. From genomic organization to synaptic plasticity, biomolecular condensates
influence wide-ranging cellular mechanisms. Despite these exciting insights, the biophysical and physiological
properties of the underlying IDP-assemblies remain poorly understood. This knowledge gap is pervasive
because existing tools to study IDPs and their LLPS require non-physiological conditions. The major challenge
is the pronounced environmental sensitivity of IDPs. Their LLPS behavior is unpredictably altered by
environmental and biochemical changes, including post-translational modifications (PTMs) and molecular
tagging with fluorescent proteins. New tools are needed to dissect biomolecular condensates in their native
cellular environments, within tissues. Progress towards in tissue non-disruptive probing of IDP-assemblies will
close the gap separating IDP biophysics and IDP-linked disease mechanisms. Crucially, while IDP-assemblies
are pathological hallmarks of untreatable degenerative brain disorders, decades-old and LLPS-refined
observations have failed to provide mechanistic insights. Motivated by these challenges, this proposal
advances biomolecular sensors to probe and manipulate intracellular IDP-assemblies in brain-like tissues. The
crucial innovation is the encoding of ultra-weak and LLPS-specific multivalent interactions into engineered
IDPs equipped with fluorescent and catalytic domains. The resulting IDPs will serve as multifunctional LLPS-
sensors, enabling a strategic departure from molecular tagging of native IDPs. This engineering platform builds
on fluorescent LLPS-sensors recently pioneered to illuminate LLPS dynamics in skin. By catalyzing
biotinylation and protein-disaggregation, next-generation LLPS-sensors will enable biomolecular dissection of
IDP-assemblies and provide tools for combating neuropathological IDP-assemblies. To advance and deploy
these innovations, this proposal will engineer and interrogate multifunctional LLPS-sensors in state-of-the-art
brain organoid models of Alzheimer's disease, frontotemporal dementia, and amyotrophic lateral sclerosis.
Combining sensor-enabled live cell imaging and proximity proteomics, the proposed experimental approaches
will address long-standing key questions linking pathological IDP-assemblies and major human
neurodegenerative disorders. By adding molecular tools and rigor to the modeling of neuropathology in brain
organoids, this work will enable and stimulate molecular-level dissection of age-dependent human
neurodegeneration. Beyond generating therapeutic insights into IDP-driven mechanisms of neurodegeneration,
this proposal will advance a broadly applicable sensor-organoid platform to study biomolecular condensates
across biological systems.

Public health relevance
Project Narrative Intracellular assemblies of intrinsically-disordered proteins (IDPs) are pathological hallmarks of untreatable human neurodegenerative disorders. Preventing therapeutic innovation, current technologies fail to probe and manipulate the dynamics of IDP-assemblies (e.g., their formation and maturation) and related biomolecular condensates in their native tissue contexts. This proposal innovates intracellular protein-sensors of IDP self- assembly, integrated with state-of-the-art brain organoids, to generate biophysical, biochemical, and therapeutic insights into IDP-driven mechanisms of human neurodegeneration.